Impact of Per/Polyfluoroalkyl pollutants on vascular disease mechanisms

Project Summary/Abstract
Per- and polyfluoroalkyl substances (PFAS) are manmade chemicals that are extensively used in
industrial and consumer products such as stain- and water-repellent fabrics, food contact materials,
polishes, waxes, paints, and foams. PFAS have exceptionally long half-lives, can bio-accumulate in
humans, and are omnipresent in the environment including our food and drinking supplies. This
proposal will focus on the growing evidence that PFAS exposures are associated with negative health
outcomes and may play a role in the pathogenesis of cardiovascular diseases. Our preliminary data
show that PFAS disrupt key physiological functions of human blood vessels by impairing arteriolar
vasomotor function and angiogenesis. In this application, we will seek to characterize, to our knowledge
for the first time, causal pathophysiological actions of diverse classes of PFAS toxicants upon the
human vascular system. To achieve our objectives, we will employ complementary approaches
harnessing physiological studies of vasodilator function and angiogenesis, and mouse models tailored
to human-relevant conditions and chronic exposure scenarios to gain novel insights into mechanisms of
PFAS-mediated vascular disease. In Aim 1, we will characterize the effects of PFAS pollutants on the
human adipose tissue microvasculature by examining endothelium-dependent and –independent
vasodilator responses using videomicroscopy in live intact arterioles, and perform angiogenic assays
from human fat biopsies collected during elective surgical procedures in 50 male and female subjects.
We will test the hypothesis that select PFAS have negative effects upon the human vascular system.
Aim 2 will investigate the ability of specific PFAS, using chronic, low-dose, human-relevant exposure
scenarios to induce the development of vascular dysfunction and atherosclerosis in male and female
mouse models that express the human PPARα gene and fed an American diet. We will test the
hypothesis that long-term exposure of select PFAS toxicants can impair vascular function and induce
atherosclerosis in vivo. Our approach includes a diverse complementary team involving clinical
cardiovascular (Dr. Gokce) and environmental toxicology (Dr. Schlezinger) expertise, and combines
studies of physiology utilizing live human biospecimens, molecular toxicology, and an in vivo murine
chronic exposure model to study acute and long-term effects of PFAS upon the vasculature. The
overall project tackles an unmet clinical need for innovative research as outlined by the recently
established PFAS Commitments to Action Strategic Roadmap (2021-2024) by the EPA, for
understanding how PFAS pollutants can play causal roles in mediating human disease. This overall
project is positioned to move the field forward, and may lead to the identification of new interventions
and public health approaches to mitigate toxicant-induced cardiovascular diseases.

Public health relevance
Project narrative Per- and polyfluoroalkyl substances (PFAS) are manmade pollutant chemicals that are extensively used in consumer products. PFAS have contaminated our food and water supplies, bio-accumulate in human tissues, and have been linked to several health hazards including the cardiovascular system. This proposal will investigate mechanisms by which PFAS toxicants disrupt endothelial homeostasis and cause vascular disease, which represents a topic of high public health significance affecting nearly every individual living in the United States.